High-Content in vivo DNT Test Batteries using Cell-Specific Characterization of the Neurodevelopment and Synaptogenesis in C. elegans as NAMs

Neurodevelopmental disorders such as ADHD, autism, and learning disabilities are rising globally. In the US, 1
in 6 children suffer from some form of developmental disability. One potentially important factor in their increase
is exposure to chemicals of unknown toxicity in the environment. While there are over 350,000 chemicals in
commercial use and around 13,000 produced in large amounts, only a small percentage have known
toxicological data. Current testing methods for developmental neurotoxicology (DNT) are mostly based on
observing behavioral, physiological, and anatomical defects in small mammals. These studies are prohibitively
time-consuming and expensive for testing the huge backlog of commercial chemicals, and may produce hard-
to-interpret results due to the complexity of observed endpoints and differences between multiple laboratories.
Additionally, many jurisdictions are limiting the numbers of animals that can be used for testing. New approach
methodologies (NAMs) are a new paradigm in toxicology testing that bring together alternative approaches such
as in silico predictions, cell culture, and microphysiological systems-based assays, plus alternative model
animals such as zebrafish, drosophila, and C. elegans. While in silico and in vitro methods can provide high
throughput testing at much lower costs than mammalian studies with easier to interpret and predictive results, in
vitro methods still have substantial costs and complex culturing conditions and neither approach can recapitulate
the effects of a substance on a complete developing organism. C. elegans is an ideal alternative animal model
for DNT testing. It has a complete nervous system with a fully characterized connectome and neuronal lineages,
most of the same important neurotransmitter systems as humans, is fast and easy to grow to maturity in large
numbers, and is amenable to targeted genetic manipulation. We propose to use C. elegans in a comprehensive
DNT test battery where we will track neuronal, synaptic, and behavioral changes as the organism develops from
late larval to adult stage after early exposure to DNT toxicants. In Aim 1, we will develop novel reporter strains
with fluorescent markers for GABAergic and dopaminergic neurons and synapses, expose them to reference
chemicals, and monitor the behavior of growing animals in culture before imaging them on our high-content
microfluidic imaging platform at L4 and D1 stages. Specific behavioral endpoints will be analyzed by ML-based
approaches from the behavioral videos. The high-resolution whole-body 3D images from on-chip imaging will be
analyzed by semi-automated methods for key DNT indicators such as neuronal loss and mislocalization,
membrane blebbing, and defective or missing synapses. All these endpoints will be combined to find the dose
of a chemical at which the point of departure from the control occurs. In Aim 2, we plan to investigate potential
modes of action using expression analysis of developmental and stress genes. We will test a representative
subset of chemicals from the DNT-DIVERS library to establish confidence in our model and lay the foundations
for a fully automated low-cost, high-throughput DNT testing method to assess the risks of common chemicals.

Public health relevance
Developmental disorders such as ADHD and autism are increasing among children, in part caused by exposure to chemicals in their environment with potentially neurotoxic effects. Current testing methods using small animals such as rats and mice are too slow, expensive, and increasingly limited by welfare regulations to test the effects of all chemicals in commercial use for how they affect nervous system development. We propose to use the small nematode C. elegans and develop a battery of tests based on their behavior and examinations of their developing neurons and synapses after exposing them to chemicals to predict the adverse effects of the chemical on the developing human brain.